(2/2) TUFCCC/HC Regional Comprehensive Cancer Health Disparity Partnership

PROJECT SUMMARY
Overall
TUFCCC: Grace X. Ma, PhD (Contact PI) and Jean-Pierre Issa, MD (MPI)
HC: Olorunseun O. Ogunwobi, MD, PhD (Contact PI) and Joel Erblich, PhD, MPH (MPI)
Despite advances in early detection and treatment of cancer, significant racial/ethnic disparities exist in African,
Asian-Pacific, and Hispanic Americans, bearing disproportionate cancer burden. These cancer health
disparities are particularly salient in the Pennsylvania-New Jersey-New York City (PNN) region, where there is
a high concentration of minority populations compared to elsewhere in the U.S. Moreover, despite numerous
academic institutions conducting biomedical research in PNN region, there is a critical dearth of
underrepresented minorities (URMs) involved in cancer research, who bring unique scientific and cultural
strengths necessary to conquer cancer health disparities. Building on collaborative history, successful and
synergistic planning activities/accomplishments between TUFCCC and HC, and NCI-funded cancer disparities
research networks (CNPC), we propose to establish TUFCCC/HC Regional Comprehensive Cancer Health
Disparities Partnership to reduce cancer health disparities in PNN region. The goals of this Partnership are to:
a) develop a strong and sustainable collaborative cancer health equity research infrastructure, b) support the
development of outstanding URM students and ESIs who are committed to careers in cancer research, and c)
collaboratively engage the community in enhancing quality and feasibility of these efforts. These goals will be
achieved through the following specific aims: Aim 1. Create and enhance sustainable cancer disparity
research collaborations in URM populations between TUFCCC and HC. Aim 1a. Enhance institutional cancer
research capacity at HC in basic, behavioral and clinical cancer research and provide HC researchers with
access to cancer core facilities, resources and expertise at TUFCCC. Aim 1b. Increase the number of
research projects at TUFCCC that focus on cancer health disparities in underserved populations throughout
the PNN region. Aim 2. Provide research education opportunities in cancer disparities to support a pipeline of
diverse and URM undergraduate and graduate students at HC and TUFCCC. Aim 3. Establish a sustainable
career development program to increase the number and diversity of investigators/ESIs to conduct cancer and
cancer disparity research at both HC and TUFCCC. Aim 4. Use a Community-Based Participatory Research
approach to engage researchers, students and community leaders to develop and implement culturally
appropriate collaborative cancer outreach, research and education initiatives to increase access to, and
utilization of cancer prevention, early detection and treatment in underserved disparity populations. To achieve
U54 goals/aims, the Partnership includes two innovative and rigorous full research projects, a pilot project and
a series of integrated cores, including Research Education, Planning and Evaluation, Community Outreach,
and Biostatistics/Bioinformatics. Administrative Core will provide oversight and cohesion to the Partnership.
Finally, the Partnership has a high level of institutional commitments from both TUFCCC and HC and is well
positioned to make significant contributions to advancing cancer health equity in PNN region and beyond.

Public health relevance
PROJECT NARRATIVE Overall Despite advances in cancer treatment and research, there are significant racial/ethnic cancer health disparities in cancer incidence and mortality, with African, Asian-Pacific, and Hispanic Americans bearing disproportionate cancer burden. Building on collaborative history, successful and synergistic planning activities/accomplishments between TUFCCC and HC, as well as NCI-supported cancer disparities research networks, we propose to establish TUFCCC/HC Regional Comprehensive Cancer Health Disparities Partnership to reduce cancer health disparities among underserved minority populations in Pennsylvania-New Jersey-New York City (PNN) region, through cancer disparities research, community outreach, and career development for underrepresented early stage investigators and students. The proposed U54 Partnership, in concert with two highly committed and collaborative institutions, is well positioned to jointly make significant contributions to advancing cancer health equity in the PNN region and beyond.